Self-nonself recognition and multicellularity in myxobacteria: Equipment supplement

Abstract (from parent grant R35GM140886)
A fundamental question in biology is how individual cells within a multicellular organism
recognize other cells as self to cooperatively function in tissues, organs and as whole individuals.
To address this complex question, we study a relatively simple and experimentally trackable
model organism, Myxococcus xanthus. Although a bacterium, M. xanthus exhibits many traits
found in tissues and more complex multicellular species. One trait is multicellular development
in response to starvation. Another trait, we discovered, is the ability of cells to distinguish
between self and nonself for the exchange of cellular proteins and lipids. Recognition is mediated
by a polymorphic cell surface receptor called TraA and its partner TraB. Only cells that bear
identical or nearly identical TraA receptors engage by homotypic interactions. Social outcomes
from this process, called outer membrane exchange (OME), vary depending on the properties of
the interacting cells. In some cases, OME leads to cooperative interactions whereby healthy
donors repair damaged cells by replenishing their cell components. In other cases, OME leads to
antagonism when partnering cells are not clonal. Discrimination occurs by polymorphic toxin
transfer to recipient cells that lack cognate immunity.
Our future goals are multifaceted with respect to understanding OME and, more broadly, how
cells recognize self and transition toward multicellularity. Over the next five years we will
critically examine how OME leads to cooperativity. One area of investigation is how TraA/B
directs emergent behaviors in populations that include synchronized and coordinated
movements. This will be explored by monitoring global gene expression and how TraA/B
interacts with a signal transduction pathway that controls motility. Cell synchronization is being
studied with a biosensor the monitors’ calcium fluxes in cells. Other approaches will probe how
M. xanthus responds and adapts to environmental stresses, whereby those adaptations are
transferred to naïve populations by OME. A second area of research addresses how myxobacteria
rapidly diverge into different social groups in natural environments. Our preliminary findings
indicate that horizontal gene transfer by non-lytic transducing particles mediate population
divergence by carrying polymorphic genes involved in social discrimination. A third focus area
will elucidate the mechanism of OME thought to involve outer membrane fusion. Finally, we will
explore new mechanisms of self-recognition and its role in multicellular life.

Public health relevance
Narrative (from parent grant R35GM140886) Self-nonself recognition is an essential function that maintains and protects cooperative interactions among cells in a multicellular organism. As an example, our immune system interacts harmoniously with our own tissues, while eliminating foreign pathogens and non-cooperative cancer cells. This proposal investigates a new paradigm for cellular self-recognition and how cells assemble cooperative multicellular behaviors